Simultaneous Hadamard Editing of GABA and Glutathione

PROJECT SUMMARY Edited magnetic resonance spectroscopy allows the non-invasive detection of low-concentration metabolites within the brain, such as the inhibitory neurotransmitter GABA and the redox compound glutathione (GSH). The signals of such metabolites are often overlapped in the MR spectrum, but a tailored spectral editing experiment can selectively retrieve signals of interest. Such “edited” approaches generally focus on measuring a single metabolite (i.e. either GABA or GSH) in a single brain region; the main goal of this proposal is to develop Hadamard-edited experiments that detect GABA and GSH simultaneously, in a single acquisition. We will develop the Hadamard-encoded HERMES approach, and multi-voxel Hadamard editing, using the SHERPA and HERMES-SHERPA approaches. The resulting data acquisition, post- processing and analysis tools will be made available for dissemination to the clinical neuroscience and neuroimaging communities.

Public health relevance
Project Narrative Magnetic resonance spectroscopy measures the concentration of naturally occurring chemicals within the body using an MRI scanner to, often focusing on one particular chemical and location using “edited” methods. This project will develop new experimental and data processing tools to allow simultaneous edited measurements of two key brain compoudnds, GABA and glutathione.